ALCOHOL CUE LABORATORY STUDY TESTING ANS-6637 - CONTRACT RESEARCH ORGANIZATION STUDY AND DATA MANAGEMENT

Medications Development Clinical Trials Network for the Treatment of Alcohol Use Disorder ? Contract Research Organization (CRO) - Fast Track Drugs and Biologics